An individualized medicine approach to urinary stone disease

ABSTRACT
Urinary stone disease (USD) affects up to 12% of individuals in developed countries, and is associated with
significant morbidity, pain, and annual US health care costs of >$10 billion. There is strong evidence of
heritability, however risk factors remain relatively obscure. Our prior work in the Rare Kidney Stone
Consortium (RKSC) developed a targeted nephrology gene capture panel (tNGS) with 144 known and
candidate USD genes and resolved ~30% of >500 patients suspected of monogenic USD due to early onset
nephrolithiasis (NL), nephrocalcinosis (NC), chronic kidney disease (CKD), and/or multiple stones, with ~15
different genes implicated. In addition to making a definitive diagnosis, in many cases the resulting information
revealed new treatment options or directed patients to specific clinical trials. Here we propose extending our
understanding of the spectrum of genes and variants associated with monogenic NL/NC in the RKSC cohort,
including functional in vitro analyses of variants of uncertain significance (VUS; Aim #1). In parallel, we will
study a cohort of >50,000 Mayo Clinic biobank patients with detailed linked medical record information
(~12.7% with stones) (Aim #2). Findings in this Biobank cohort will be validated and extended in a Prospective
Kidney Stone Cohort of more than 550 first time USD patients and 480 matched controls (Aim #3). This third
community-based cohort has detailed clinical and biochemical data, including comprehensive assessment of
symptomatic and radiographic recurrence, and will thus allow detailed study of potential mechanism(s) of
implicated genes. This proposal takes advantage of available genetic analyses in Aim #2 and Aim #3 that
includes whole exome sequence (WES) as well as genomewide single nucleotide polymorphism (SNP) data
for association studies. Studies will determine if coding, noncoding, and expression related variants of
monogenic USD genes are associated with NL/NC risk and correlate with biochemical determinants of stones.
Our Specific aims are: Aim #1: Genotype patients suspected of monogenic forms of USD using global
NGS approaches; Aim #2: Validate identified genetic USD risks in a Mayo Clinic Biobank cohort including first
time and recurrent calcium stone patients and controls with WES and SNP association studies; Aim #3:
Characterize genetic USD risks and pathways in a prospective chart-validated cohort of first-time symptomatic
calcium stone patients with age-sex- matched controls with WES and SNP association studies.
Our overall hypothesis is: variants in monogenic USD genes not only explain Mendelian disease, but are
risk factors for the common (predominately calcium) USD that is found in the general community. This study will
improve understanding of the etiology and pathogenesis of monogenic USD and impact patient treatments and
clinical trial recruitment. Risk factors for common US and its recurrence will also be identified.

Public health relevance
PROJECT NARRATIVE Urinary stone disease (USD), is extremely common, affecting up to 12% of individuals in developed countries, is associated with signiﬁcant morbidity including pain, hospitalizations, surgical procedures, and lost work time, and is often recurrent and can lead to progressive chronic kidney disease (CKD). There is strong evidence for a genetic component to both rare and common causes of USD. This proposed project will examine in great detail candidate genes implicated in USD to increase understanding of the underlying pathogenic events, suggest new treatments, and allow assembly of homogeneous cohorts of affected individuals for future study.